EM OF RECOMBINATION MUTANTS IN DROSOPHILA

The roles of the synaptonemal complex and of the recombination nodule in insuring normal meiotic recombination are being examined by electron microscope serial section reconstruction analysis of oocytes of wild-type and of recombination-defective meiotic mutants of Drosophila melanogaster.